Western States Occupational Network (WestON) meeting

Over the past decade, the Council of State and Territorial Epidemiologists (CSTE) has worked in
collaboration with the National Institute for Occupational Safety and Health (NIOSH) towards the
goal of increasing state-based occupational health surveillance capacity. A long-term goal of the
CSTE Occupational Health Subcommittee is to build, in collaboration with NIOSH, minimum
capacity for the surveillance of work-related injuries and illnesses at the state level. The overall
goal of the WestON meeting is to strengthen state-based occupational epidemiology in the
Western region through capacity building and scientific collaboration, including the ongoing
surveillance of work-related injuries and diseases, investigation of cases and outbreaks, and
dissemination of information for public health prevention. By convening state-based occupational
health epidemiologists and scientists from 19 western states, NIOSH and OSHA federal partners,
and the NIOSH-funded Education and Research Centers (ERCs) and Agricultural Research
Centers, the WestON meeting addresses the large burden of work-related injuries and illnesses
in the rapidly growing Western states, the need to enhance state-based occupational safety and
health program capacity, and has an impact by providing training and content for new and
established state-based occupational epidemiology efforts.
The WestON meeting aligns with several NIOSH NORA Sector and Cross-Sector Program
goals, including Agricultural, Forestry and Fishing (AFF); Mining; Oil and Gas Extraction; and
Respiratory Health. In addition, the WestON meeting aligns with the goals of the NIOSH Health
Hazard Evaluation Program and Worker Health Surveillance Health. By bringing partners
together to present and discuss topics of scientific and public health importance, the WestON
meeting also aligns with the NIOSH 2019-2023 Strategic Goals to reduce occupational immune,
infectious, and dermal disease; occupational musculoskeletal disorders; occupational
respiratory disease; improve workplace safety to reduce traumatic injuries; and promote safe
and healthy work design and well-being. Within the NORA Sectors noted above, topics at the
WestON meetings address Intermediate Goals 1.1 Pesticide Exposure and Neurologic
Disorders; 3.1, 3.3 and 3.6 Infectious Disease Transmission; 3.4 Exposures Related to Asthma;
4.2 and 4.8 MSD Interventions; 4.4 MSD Risk Factors; 4.5 Risk Factors for Back Injuries; 5.1
Fixed Airways Diseases; 5.2 and 5.8 Exposure to Mineral Dusts; 5.4 and 5.7 Work-Related
Asthma; 5.5 Dust-Induced Respiratory Diseases; 5.6 and 5.11 Fixed Airways Diseases; 5.10
Silica-Induced Respiratory Diseases; 6.1 Traumatic Injuries Among High Risk Populations; 6.5
and 6.6 Machine-related injuries; 6.9 Excessive Heat Exposure; 6.11 Motor Vehicle Crashes;
6.13 Falls; 6.14 Transportation Incidents; 6.15 Machine-related injuries; 6.16 Slips, Trips and
Falls; 7.1, 7.5 and 7.10 Non-standard Work Arrangements; and 7.2 Work Organization.
Short-term outcomes include participant demographics which help assess the representation by
all western state health departments; general satisfaction with the meeting; usefulness of each
session of the meeting; changes in knowledge/abilities per and post meeting; representation
and participation by all 19 western state health departments; and engagement by regional
ERCs, Agricultural Centers, universities and worker organizations. Intermediate (medium-term)
outcomes include improving occupational injury surveillance in western states; increasing
occupational injury prevention interventions; identifying western occupational health priorities
and issues; increasing completion of Occupational Health Indicators by Western states; and
increasing collaborative publications and presentations at national conferences. The key long-
term outcome of the WestON meeting is to increase the occupational epidemiology capacity in
the 19 Western states.

Public health relevance
The overall goal of the Western States Occupational Network (WestON) meeting is to strengthen state-based occupational epidemiology in the Western region through capacity building and scientific collaboration, including the ongoing surveillance of work-related injuries and diseases, investigation of cases and outbreaks, and dissemination of information for public health prevention. The WestON meeting aligns with several NIOSH NORA Sector and Cross-Sector Program goals, including Agricultural, Forestry and Fishing (AFF); Mining; Oil and Gas Extraction; Health Hazard Evaluation; and Surveillance.